Optimizing and Personalizing interventions for schizophrenia Across the Lifespan (OPAL)

The OPAL Center is named after its goal of Optimizing and Personalizing interventions for people with
schizophrenia Across the Lifespan. The target population for this ALACRITY Center is people diagnosed with
schizophrenia, which typically affects individuals from adolescence or early adulthood until the end of life.
Affected individuals commonly have impaired social and occupational functioning; experience persistent
psychotic and mood symptoms; have cognitive problems that may progress; and are at risk for disability and
premature death. Black, Indigenous, and People of Color (BIPOC) individuals are particularly at risk of poor
outcomes. The goal of this renewal application is to extend our efforts to accelerate the development and
implementation of effective, individualized treatments for schizophrenia in real clinical settings.
The specific aims of the Center renewal application are as follows:
1. Strengthen our infrastructure that supports research that examines innovative ways to optimize
treatments for people with schizophrenia throughout the lifespan and that accelerates the translation of clinical
research on schizophrenia to routine practice settings.
2. Conduct projects that develop, adapt, and test innovative, accessible, and person-centered interventions
that improve engagement in treatment and can be readily deployed.
3. Train scientists who will conduct translational research on interventions for schizophrenia.
The OPAL Signature Project will use 16 years of data (2007-2022) from the Center for Medicaid and
Medicare Services (CMS) to test hypotheses about risk factors for dementia among people diagnosed with
schizophrenia and compare the effectiveness of treatment strategies after diagnosis of dementia. We will then
integrate our findings to adapt a Cognitive Health Toolkit that provides assessment and management tools.
Exploratory Project 1 tests a novel, person-centered approach to assessment and treatment initiation
for BIPOC individuals with psychotic symptoms in community mental health clinics that incorporates an
adapted version of the Cultural Formulation Interview to improve diagnosis and treatment engagement.
Exploratory Project 2 will build on work done in Europe to adapt and test the feasibility and
preliminary effectiveness of Flexible Assertive Community Treatment (ACT), which will allow ACT teams to
allocate resources according to the individual needs of participants, improving efficiency and outcomes.
Exploratory Project 3 uses mobile health (mHealth) technology to deliver measurement-based care
and improve the person-centered outcomes of individuals with schizophrenia across the lifespan.
OPAL projects use the Center's common resources and methodologies to improve implementation and
personalization of treatments for important problems. Stakeholders help us to refine and adapt interventions for
effective implementation in real-world settings.

Public health relevance
The target population for this ALACRITY Center is individuals affected by schizophrenia or related disorders, who are at risk for poor outcomes including persistent symptoms, progressive cognitive problems, disability, homelessness, and premature mortality. Black, Indigenous, and People of Color (BIPOC) are particularly at risk of poor outcomes. The goal of this renewal application is to extend our efforts to accelerate the development and implementation of effective, individualized treatments for schizophrenia in real clinical settings.